Engineered Cytokines Targeting Lipid-Laden Macrophages

PROJECT SUMMARY/ABSTRACT
Cytokine therapies have the potential to revolutionize treatment for immunologic diseases but are limited by their
poor pharmacokinetic profiles, off-target effects, and pleiotropic nature. Engineered cytokine platforms, on the
other hand, have the potential to target specific tissue environments and cell types to provide local
immunomodulation with minimal side effects. Since macrophages play a central role in many immune-mediated
diseases and can be polarized toward anti-inflammatory or pro-inflammatory phenotypes, they are promising
targets for cytokine therapies. In my preliminary work, I developed a platform technology to target metabolically
dysfunctional macrophages in the context of atherosclerosis, a paradigm chronic inflammatory disease with high
prevalence. Since macrophages that comprise atherosclerotic plaques engulf large amounts of low-density
lipoprotein (LDL) and become pro-inflammatory lipid-laden “foam cells,” I engineered a protein fusion in which
one side is an antibody fragment (Fab) that binds to LDL and the other side is the anti-inflammatory cytokine IL-
10. I have shown that Fab-IL-10 constructs attach to LDL upon i.v. injection in hypercholesterolemic mice,
hitchhike a ride to inflamed regions, preferentially target macrophages, and successfully reduce inflammation.
This proposal aims to elucidate the molecular mechanisms of action whereby inflammation is locally suppressed
in atherosclerosis (Aim 1), engineer additional functionalities into the construct (Aim 2), and determine its
generalizability to other cytokine payloads (Aim 3). In Aim 1, we will primarily use in vitro models to dissect the
roles of different scavenger receptors involved in Fab-IL-10 binding and uptake and characterize the resulting
phenotype and transcriptome of Fab-IL-10-treated lipid-laden macrophages. We will also perform single cell RNA
sequencing on plaque-resident macrophages in an experimental mouse model of atherosclerosis to determine
the effects of treatment with Fab-IL-10 in vivo. In Aim 2, we will engineer and evaluate an LDL-binding full
antibody-IL-10 construct with enhanced avidity due to multiple binding regions, extended half-life due to neonatal
Fc receptor-mediated recycling, and higher potency due to an extra copy of IL-10 per construct. In Aim 3, we will
evaluate the generalizability of this platform to other payloads while also uncovering biological insights on the
effects of less well-studied cytokines in atherosclerosis (i.e., IL-19 and IL-33). With data generated from this
proposal, we will apply to multiple R01-level grants to expand this platform to target additional disease models
that are partially regulated by lipid-laden macrophages including non-alcoholic fatty liver disease and certain
solid cancers. This research proposal combined with my individualized career development plan will enable me
to expand my scientific and professional skillsets and will enable my seamless transition to research
independence as a future tenure-track assistant professor.

Public health relevance
PROJECT NARRATIVE Cytokines are powerful modulators of the immune system, but cytokine therapies have had limited clinical success due to off-target side effects. To circumvent these limitations, this research proposes to engineer a platform technology that delivers these protein drugs where they are needed in multiple different immune- mediated diseases.